PancreasFest 2023

SUMMARY
Advancing our understanding of human pancreatic diseases, especially pancreatitis and pancreatic cancer,
requires the cooperative effort of a network of clinical centers of excellence and the regular meeting of thought
leaders in the field. The course objectives for PancreasFest 2023 will enhance progress on meeting research
priorities highlighted by the National Commission of Digestive Diseases. Specifically, we will 1) Critically review
genetic and environmental risk factors associated with development of pancreatic diseases; 2) Critically review
new advances in management of acute and chronic pancreatitis patients;3) Discuss potential approaches and
advances aimed to improve the early detection and treatment of pancreatic cancer patients 4) Discuss
strategies for translation of new scientific discoveries into clinical trials and practice, including needs analysis.
The University of Pittsburgh has organized and hosted PancreasFest and its precursors since 1994. We are
honored to expand and enhance conference reach and breadth through the 2023 transition of conference
leadership to CAPER (Collaborative Alliance of Pancreatic Education & Research), a nonprofit devoted to
enhancing the career development of junior physician scientists in the field of pancreatology.
No other conference in the US focuses exclusively on fostering translational multi-center programs for
pancreatic disorders. Attendees of past meetings uniformly praise PancreasFest for fostering collaborative
research and for its emphasis on the importance of a small conference focused on pancreatic disorders.
Multiple clinical working groups have emerged over the years through PancreasFest that focus on areas of
NIDDK interest. Approximately 250+ medical professionals from varied medical disciplines register for
PancreasFest each year, including physicians and scientists interested in the pancreas: pancreatologists,
endoscopists, surgeons, radiologists, pathologists, molecular biologists, pediatricians, geneticists,
epidemiologists, statisticians, systems biologists, subspecialty medical professionals, and experts in
biomarkers. We encourage attendance from new faculty and fellows to ensure that the next generation of
pancreatic investigators works directly with and learns from senior researchers in the field. Key staff from the
NIDDK are invited to provide perspective and discuss priorities. PancreasFest is also attended by
representatives from industry and patient-focused foundations, such as CAPER, Mission:Cure, and the
National Pancreas Foundation.
PancreasFest 2023 will be held at the University of Pittsburgh William Pitt Student Union in the Oakland
section of Pittsburgh, PA on July 27-28, 2023. NIDDK-sponsored sessions will be part of PF23, which include
meetings from the International Study Group of Pediatric Pancreatitis In Search of a Cure (INSPPIRE) and the
annual meeting of CAPER.

Public health relevance
NARRATIVE PancreasFest 2023 will benefit patients who have had and are at risk for pancreatitis, pancreatic cancer, and other pancreatic disorders by providing a forum for leading experts in the field of pancreatology to discuss results of current research. PancreasFest 2023 will identify the best methods for diagnosing, treating, mentoring, and preventing pancreatitis, pancreatic cancer and other pancreatic diseases. No other conference focuses on these disorders from a translational research and clinical implications perspective. The meeting format encourages all attendees to participate in discussion related to providing the best possible clinical care.